Revisiting Antiangiogenic Therapy to Target Hormone-Sensitive Prostate Cancer Metabolism

PROJECT SUMMARY
In patients with advanced prostate cancer, phase III clinical trials of angiogenesis inhibitors with standard of care
therapies demonstrated clear antitumor activity but failed to improve overall survival. Why some men benefited
from those therapies while others did not remains unclear. Our preliminary data indicate that blockade of
anaplerotic signaling pathways, which replenish metabolites syphoned from the tricarboxylic acid (TCA) cycle
for rapid growth, by inhibition of CAMKK2 or glutaminase, while initially effective, invariably gives way to CAMKK2
or glutaminase inhibitor resistance. Notably, we found that a common feature of these relapsed tumors is
increased angiogenesis. Indeed, analysis of patient-derived tumor specimens indicate that there exists a
compensatory association between angiogenesis and anaplerotic signaling pathways, suggesting that when one
process is low, the other needs to be high to sustain the tumor’s metabolic demands, with the strongest inverse
association occurring in hormone-sensitive prostate cancer. The goal of this proposal is to evaluate whether co-
targeting cancer cell anaplerotic metabolism and tumor angiogenesis can synergize to treat hormone-sensitive
prostate cancer. We also seek to determine whether biomarkers of anaplerotic signaling can predict response
to antiangiogenic therapy and therefore, guide patient selection. It is our central hypothesis that blocking
angiogenesis forces cells into a state of semi-starvation that compromises anaplerosis and dramatically
enhances tumor sensitivity to inhibition of central carbon metabolism. We further hypothesize that biomarkers of
anaplerotic signaling can predict response to antiangiogenic therapy. We will test our hypotheses with the
following aims: Aim 1 will evaluate angiogenesis as a mechanism of resistance to CAMKK2 inhibition and
anaplerotic stress. We will investigate synergy between CAMKK2 and VEGF inhibition in models of hormone-
sensitive prostate cancer with or without surgical castration and characterize the effects on anaplerosis using
bulk and imaging mass spectrometry, as well as their impact on tumor features via MRI, histopathology, and
immunohistochemistry. Aim 2 will determine if a clinical-grade inducer of anaplerotic stress sensitizes prostate
cancers to the antitumor effects of antiangiogenic therapy. To further evaluate our central hypothesis, Aim 2 will
determine the effects of an inhibitor of glutaminase, which also blocks anaplerosis. Aim 3 will assess whether
anaplerotic signaling predicts for sensitivity to antiangiogenic therapy in patients. To do this, we will interrogate
two completed, tissue-rich phase II trials that tested the presurgical efficacy of the antiangiogenic agents axitinib
and sunitinib in men presenting with high-risk, very high-risk, and early metastatic prostate cancer. This research
is highly significant and innovative because it will: 1) set rationale for a new form of drug combinations integrating
metabolic modulators and antiangiogenics for the treatment of hormone-sensitive prostate cancer; 2) develop
new candidate biomarkers to guide patient selection for clinically active angiogenesis inhibitors in treatment
schemas for prostate cancer; and 3) facilitate new drug discovery efforts targeting CAMKK2.

Public health relevance
PROJECT NARRATIVE To make significant leaps in the treatment of prostate cancer, mechanistically novel therapeutic approaches are needed. This proposal explores new approaches to target prostate cancer metabolism and tests potential biomarkers for antiangiogenic therapy, which have known antitumor effects but are yet to meaningfully extend life in men with prostate cancer.